Applying an Implementation Science Lens to Defragmenting Care for Patients at Increased Risk of Hospitalization: A Conference on Comprehensive Care

Project Summary/Abstract
This application requests support for a novel 1-year dissemination and implementation conference grant in which
the University of Chicago Comprehensive Care Physician (CCP) Program research team will engage 65-75
health care leaders, clinicians, social service providers, and patients through an in-person 1.5-day conference
in Chicago and monthly virtual sessions for the duration of the project period. Building on our successful AHRQ-
supported inaugural Comprehensive Care Conference in 2023, the conference will focus on sharing
dissemination tools and implementation frameworks for evidence-based care delivery models that increase
relational continuity across inpatient and outpatient settings for patients at increased risk of hospitalization and
address complex medical and social needs. This focus is motivated by evidence that greater continuity of care
can improve outcomes for patients at increased risk of hospitalization. This evidence includes studies of our CCP
Program that find that providing patients at increased risk of hospitalization access to care from the same doctor
in and out of the hospital can reduce hospitalization and improve health outcomes. As a result of these positive
findings, interest in implementing similar comprehensive care models has grown, with several community and
academic medical centers across the U.S. and internationally adapting CCP in their settings with our guidance.
This proposal builds on several years of successfully facilitating relevant learning collaboratives that have
engaged a diverse set of health care providers and health system types through virtual meetings in the context
of COVID-19, including a recent Comprehensive Care Grand Rounds virtual meeting series. Participants in those
meetings have expressed significant interest in building a community around “comprehensive care” with in-
person convening opportunities to share implementation best practices and evaluation methods.
We propose 3 specific aims for this conference grant:
Aim 1: To prepare for the conference by ongoing convening activities to develop new implementation tools, and
to support implementation mentorship and related implementation science professional development
opportunities.
Aim 2: To hold a conference in late 2024 that builds on the 2023 Comprehensive Care Conference and includes
presentations and workshops that focus on implementation and evaluation of comprehensive care models
including: 1) application of implementation science frameworks to implementing care models, 2) implementation
strategies focused on hybrid models to bridge to full CCP models, and 3) evaluation strategies that jointly analyze
implementation and intervention effectiveness.
Aim 3: To plan for future conferences that focus on dissemination and implementation of CCP/C4P in diverse
environments, including urban and rural community hospitals and academic medical centers.

Public health relevance
Project Narrative This application requests support to build upon a novel 1-year dissemination and implementation conference grant in which the University of Chicago Comprehensive Care Program (CCP) research team will engage 65-75 health care leaders and clinicians and social service providers through an in-person 1.5-day conference in Chicago and monthly virtual sessions for the duration of the project period. The conference will focus on applying an implementation science approach to the development, implementation, and evaluation of evidence-based care delivery models that create relational continuity across inpatient and outpatient settings for patients at increased risk of hospitalization and explicitly address both complex medical and social needs. This will be the second conference to focus on the topic of comprehensive care models, or models that defragment care for patients at increased risk of hospitalization, and through a 1.5-day conference, monthly virtual convening opportunities, and conference deliverables, including a webpage with CCP dissemination tools and learnings, will reach a diverse set of health care stakeholders and patient populations that they serve.